Mechanisms of Viral Persistence

PROJECT SUMMARY/ABSTRACT
Chronic viral infections and the co-infections they foster are among the greatest health concerns
worldwide. Although their linkage is clear, it is much less clear how one pathogen alters the
immune environment to foster another. T cells are critical both to control chronic virus infections
and to correctly orchestrate de novo immune responses against co-infecting pathogens. Thus,
we surmised that if the immune environment during chronic virus infection altered the ability to
appropriately mount T cell responses, that it would jointly and simultaneously affect the chronic
infection and susceptibility / severity of secondary infections. The goal of this proposal is to
investigate how chronic inflammation and the evolving host:pathogen interactions as viral
persistence progresses alters immunity to co-infecting pathogens. To achieve this goal, we have
developed a novel mouse model of chronic lymphocytic choriomeningitis virus (LCMV) infection
and Mycobacterium tuberculosis (Mtb) co-infection. Our preliminary data demonstrate that in the
presence of established chronic viral infection, Mtb specific immune responses are delayed,
redirected and Mtb replication increased. In the current proposal, we will mechanistically
investigate how the modulation of the immune response by the chronic virus spreads to delay
acquired Mtb-specific immunity and determine the mechanistic basis through which the altered T
cell immunity enhances Mtb disease progression. We will then examine the reciprocal relationship
between established Mtb infection and chronic viral co-infection to understand how they
comparatively impact the ability to generate and sustain simultaneous immune responses and
modulate disease course. The experiments outlined in this proposal will establish important
biologic principles and provide a new mechanistic link between the host:pathogen interactions
that foster viral persistence with those that enhance susceptibility to and severity of secondary
infections. Ultimately, the mechanisms and paradigms we reveal have the potential to lead to new
strategies to treat chronic viral infections and the co-infections that plague them.

Public health relevance
PROJECT NARRATIVE Chronic viral infections, including HIV, hepatitis C and B viruses, are among the greatest health concerns worldwide. Strategies to enhance immune activity to clear these chronic viral infections or to prevent the most devastating co-infections they promote. have so far been unsuccessful. The proposed experiments will define critical immune dysfunctions during chronic infection and develop novel immune redirecting therapies to eliminate chronic viruses and the co-infections that arise during them.